GORDON RESEARCH CONFERENCE ON MAMMARY GLAND BIOLOGY

This proposal requests funds to assist in the support of the Ninth Biennial Gordon Research Conference of Mammary Gland Biology to be held at Colby-Sawyer College in New London, New Hampshire, June 14-19, 1987. This highly successful conference with requests for attendance usually surpassing full capacity, is designed to bring together biologists from a wide spectrum of subfields, who share a major interest in the mammary gland. The program is traditionally selected to satisfy the multidisciplinary composition of the audience. The scheduled sessions include: Cellular Matrices and Differentiation in the Mammary Gland; Cell-cell Interactions; Gene Expression; Glycocongugates on the Cell Surface; MMTV and Oncogenes; Immunology of the Mammary Gland and Its Secretions; Nutritional Aspects of Mammary Development and Function; Membrane Trafficking in Secretory Systems; and Cellular "Factors" in Mammary Development and Tumorigenesis.